Multi-Organ Chart of Personalized Susceptibility to Alzheimer's Disease and Aging

Recent progress in clinical trials targeting Alzheimer's Disease (AD), including drugs like Aducanumab, has
shown promising research outcomes. However, the effectiveness of these treatments remains to be validated,
and robust biomarkers are still needed for early AD diagnosis and prognosis. Evidence suggests that AD and
related dementia (ADRD) extend beyond the brain, necessitating multi-scale modeling approaches to understand
the underlying etiology and biological mechanisms, provide computational models for precision diagnosis and
prognosis, and eventually aid in effective therapeutic strategies. The multi-scale approaches include data,
feature representation, artificial intelligence/machine learning (AI/ML), and statistical methodologies. This
proposal uses large-scale multi-omics, multi-organ biomedical data, advanced AI/ML, and computational
genomics statistical methods to study ADRD and aging. The long-term goal is to construct a Multi-organ Chart
(Multi-organ AI-derived Endophenotype called MAE) applicable in clinical settings to personalize patient
stratification and treatment strategies, predict disease risks, and select populations for future AD clinical trials.
The overarching hypothesis is that the proposed MAEs holistically model cross-organ biological and pathological
effects by linking the multi-scale causal pathway of AD: Genetics®Proteomics®Imaging (MAE)®Cognitive
decline®Disease endpoint (diagnosis), thus emerging as robust instruments for disease diagnosis and
prognosis at an individual level. The rationale for investigating this hypothesis is the multi-dimensional nature of
AD, which encompasses various factors and requires comprehensive understanding across different scales of
data and computational techniques to improve precision in diagnosis and prognosis. The overarching hypothesis
will be tested by pursuing four specific aims: i) consolidate and harmonize a large-scale multi-omics (imaging,
proteomics, and genetics), multi-organ (brain, eye, and heart imaging) consortium; ii) depict the phenotypic,
proteomic, and genetic association and causality of the imaging-derived phenotypes within the brain-eye-heart
connection; iii) construct an AI/ML-derived Multi-organ Chart to quantify individual-level susceptibility to AD and
aging, and iv) validate the clinical utility of the proposed Multi-organ Chart to predict systemic disease endpoints,
cognitive decline, as well as mortality. We will pursue these aims using an innovative combination of multi-organ,
multi-omics biomedical data and multi-resolution AI/ML methodologies, which will be built and advanced from
our previously established work. The primary expected outcomes of the proposal are to i) establish a reproducible
AI/ML Multi-organ Chart for digitizing personalized susceptibility to AD and aging and ii) promote the adoption of
multi-organ, multi-scale methodologies within the AD community through our dedicated knowledge portals, which
will be publicly accessible.

Public health relevance
The proposed Multi-organ Chart has a substantial impact on public health by potentially charting susceptibility to Alzheimer’s disease and aging at an individual level. It employs advanced artificial intelligence and machine learning (AI/ML) methodologies, coupled with multi-omics (MRI, genetics, and proteomics) and multi-organ approaches (brain, eye, and heart), to comprehensively model the neurobiological and genetic underpinnings involved in the disease. The derived individualized susceptibility scores can improve precision in diagnosis and prognosis compared to previous single-organ and single-omics approaches, ultimately improving healthcare outcomes.